Health Disparities and SARS-COV-2 Evolution: A Focused Viral Genomics Study

Health Disparities and SARS-CoV-2 Evolution: A Focused Viral Genomics Study Project Summary/Abstract We hypothesize that prolonged COVID19 illness, re-infection, and/or post-vaccine infection in patients with chronic conditions are associated with specific SARS-CoV-2 lineages or mutations, and that increasing the awareness of the potential danger posed by variants of concern will improve testing adherence and variant tracking. We propose to use our established FDA- authorized COVID19 sequencing platform in combination with innovative data analytics and clinical bioinformatics as well as our BMI and community engagement KCAs. Our proposal addresses four of the priority areas indicated by NOT-GM-21-031, specifically: ? Are there different variants present in the study population, and how has the number of cases caused by different variants changed over time in the study population? ? How are different variants distributed among different racial, ethnical, gender, and/or age groups? ? Are specific variants associated with different levels of manifestation of COVID19 symptoms? ? Do vaccinated study participants still acquire the SARS-CoV-2 virus, and if so, what variants do they carry? We propose these Specific Aims: Specific Aim 1. To improve surveillance of COVID19 by integrating SARS-CoV-2 sequencing and clinical data with a focus on under-represented, vulnerable and remote populations. Using highly automated processes, we will identify variants/mutations associated with clinical phenotypes, including prolonged asymptomatic/antibody-positive individuals, re-infected, and vaccinated populations. All trend data will be integrated in the AWS cloud where it can be accessed by relevant stakeholders including testing and vaccine program partners. Specific Aim 2. To develop and validate simulation models that incorporate SARS-CoV-2 genetic data with clinical outcomes to predict COVID19 case severity in Louisiana by region as vaccination levels increase. Specific Aim 3. To design and deploy culturally and linguistically appropriate outreach material on SARS-CoV-2 and determine whether increased knowledge of the potential danger of adaptive mutations improves acceptance of testing and vaccination.

Public health relevance
Health Disparities and SARS-CoV-2 Evolution: A Focused Viral Genomics Study Project Narrative We propose to use our CLIA-certified, FDA-authorized COVID19 sequencing platform in combination with innovative clinical data analytics and bioinformatics to test the hypotheses that prolonged COVID19 illness in patients with chronic conditions, re-infection, and/or post-vaccine infection are associated with specific SARS-CoV-2 lineages or mutations, and that increasing the awareness of the potential danger posed by variants of concern will improve testing adherence and variant tracking. Four LACaTS institutions (PBRC, LSUHSC, Ochsner and XULA) and 2 KCAs (Biomedical Informatics and Community Engagement) participate in this proposal. This project will generate unique viral genetics/molecular epidemiology data in underserved populations, improve our ability to gather unbiased viral genetics data and directly address four of the priority areas described in NOT-GM-21-031.